Developing cell type-specific enhancers and connectivity mapping pipelines for marmosets

PROJECT SUMMARY
Although genetic tools have dramatically advanced our understanding of brain function, they have
largely been confined to mice. While mice are essential models for many areas of neuroscience, there are also
many aspects of higher brain function that cannot be adequately modeled in rodents. Similarly, many brain
disorders affect higher cognitive functions that have no clear parallels in rodents. Furthermore, recent large-
scale single cell transcriptomic analyses have revealed many neuron types, connections and gene expression
patterns that are unique to primates. Thus, there is an urgent need for new genetic models that have brain
structure and function closer to humans. Non-human primates (NHP) are much more closely related to humans
than are rodents, and this is reflected in their brain development, structure and physiology. Hence, it is
increasingly recognized that they provide an attractive model to study higher brain function and brain disorders.
A promising emerging NHP model is the common marmoset, a small new world primate that has many
advantages for neuroscience and genetic research. However, lack of tools with cell type specificity has been a
major obstacle in advancing structural and functional studies in NHP. With the combined single cell RNA-seq
and single cell ATAC-seq, it is now possible to nominate short cell type-specific enhancer sequences. If
validated, these enhancers will provide an effective tool to map connectivity and interrogate function using
virus mediated expression. The difficulty lies in the identification of functional enhancers from the hundreds or
thousands of nominated potential enhancer sequences in NHP. Here we propose (1) to use a novel high
throughput in vivo approach to identify functional enhancers, and (2) to establish a whole-brain circuit mapping
pipeline for use striatal circuitry to validate our approach for cell type-specific connectivity mapping in
marmosets. When completed, these studies will provide much needed essential tools, methods and
computational pipelines for cell type-specific mapping and functional interrogation of the marmoset brain in
healthy and disease models.

Public health relevance
PROJECT NARRATIVE It is increasingly recognized that non-human primates (NHP) such as marmosets provide an essential model to study higher brain function that are not difficult to study in widely used rodent models. However, lack of tools with cell type specificity has been a major obstacle in advancing structural and functional studies in NHP. This study will develop much needed essential tools, methods and computational pipelines for cell type- specific mapping and functional interrogation of the marmoset brain in healthy and disease models.